Targeting Hippo pathway in melanoma

Summary
Constitutive activation mutations of BRAF account for majority of cutaneous melanoma, which
activate the mitogen-­activated protein kinase (MAPK) pathway, promoting tumorigenesis. While
inhibitors for BRAF, alone or in combination with MEK inhibitors, have shown good initial
responses, resistant tumors occur eventually, representing a major challenge in melanoma
therapy. Recent studies indicate that YAP, the transcription co-­activators of the Hippo pathway,
plays important roles in the development of resistance to MAPK-­blockade (MAPKi) in
melanoma. YAP interacts with TEAD transcriptional factors to drive oncogenic transcriptional
programs that are important for cancer cell growth, survival, epithelial-­mesenchymal transition
and regulation of immune response, such as recruitment of immunosuppressive Myeloid-­
derived suppressor cells (MDSCs). We have recently developed novel small molecule inhibitors
of TEADs (MGH-­CP1 and its analogues) that target TEAD auto-­palmitoylation, disrupt the YAP-­
TEAD interaction and inhibit their transcriptional activities. Moreover, we have found that the
levels of TEADs and MDSC-­attracting cytokine CXCL6, a transcriptional target of YAP, are
upregulated in MAPKi-­resistant melanoma cells, compared to their MAPKi-­sensitive
counterparts. Based on the strong scientific premise and our preliminary results, we hypothesize
that targeting the YAP-­TEAD transactivation activity with TEAD inhibitors is an effective
therapeutic strategy for MAPKi-­resistant melanomas;? and that TEAD upregulation and YAP-­
dependent recruitment of MDSCs to tumor microenvironment play important role in the
development MAPKi resistance in melanomas. The overall goal of the proposal is to
understand the role of YAP-­TEAD signaling in MAPKi-­resistant melanoma and to develop
therapeutic strategies to combat MAPKi resistance. In aim 1, we will investigate the contribution
of TEAD upregulation to the development of MAPKi-­resistance in melanoma. In aim 2, we will
evaluate the effects of small molecule inhibitors of TEADs in MAPKi resistant melanomas using
both cell culture and animal models. In aim 3, we will elucidate the contribution of YAP-­
dependent MDSC infiltration to the development of MAPKi resistance in melanoma.

Public health relevance
Project Narrative YAP is frequently aberrantly activated in cancer, including melanoma resistant to MAPK- pathway blockade. Understanding the role of YAP hyperactivation in MAPKi- resistant melanoma and development of TEAD inhibitors to target the YAP- TEAD transcriptional activity will provide novel therapeutic strategies to combat MAPKi- resistant melanoma.